Moderate effect size genes in autism spectrum disorder

Project Summary
Considerable progress has been made in identifying highly penetrant genes for autism spectrum disorder (ASD),
particularly those involving deleterious de novo mutations that are evolutionarily constrained and crucial for
developmental processes. These mutations typically result in syndromic forms of ASD with severe symptoms,
but they are rare and do not account for the majority of ASD cases. In contrast, identifying genes with a moderate
effect size (MES), which may explain the more heritable, mild, and broader ASD spectrum, has been limited.
This project aims to identify and characterize MES risk genes by integrating both rare and common genetic
variation. Our central hypothesis is that MES genes significantly contribute to ASD liability and manifestation,
particularly among individuals with a high genetic load of common variation. The central hypothesis will be tested
by pursuing four specific aims: (1) Identify and characterize MES risk genes using rare variation stratified by
common variation; (2) Identify MES risk genes on chromosome X using rare variation stratified by common
variation; (3) Identify MES risk genes contributing to ASD co-occurring conditions; and (4) Cluster MES risk
genes to identify biological pathways relevant to ASD heterogeneity. This research is significant because it sheds
light on the role of MES risk genes in ASD liability and presentation, enhancing diagnostic accuracy and
supporting clinical applications such as genetic counseling and individualized treatment options. The most
innovative parts of our proposal include (1) a novel gene discovery approach targeting MES risk genes typically
overlooked due to their subtler effects, (2) the integration of both common and rare genetic variations to
comprehensively understand their interplay in ASD, (3) investigating sex- and genetic ancestry-specific ASD risk
factors, particularly on chromosome X, and (4) identifying genetic factors that correspond to the heterogeneity
within ASD. Importantly, although methodologically innovative, we use large, established collections of
individuals diagnosed with ASD, their family members, and population controls, re-purposing these datasets to
produce novel and clinically useful findings.

Public health relevance
The proposed research is relevant to the public health mission of the NIH because it will address significant gaps in understanding the risk architecture of autism spectrum disorder (ASD). This project will test the hypothesis that moderate effect size genes contribute to the liability and manifestation of ASD. The knowledge gained is expected to have a positive impact by identifying modifiable risk factors for the risk of ASD and improving the accuracy of the recurrence risk assessment, and thus, being beneficial for counseling for parents of offspring with ASD.